Closed-Loop Stimulus Optimization to Increase Communication Efficiency in Brain-Computer Interfaces

Abstract
Assistive devices such as augmentative and alternative communication (AAC) systems are used by people with
communication and motor disabilities, such as amyotrophic lateral sclerosis (ALS, commonly known as Lou
Gehrig’s disease), to communicate and interact with their environment. There are various commercially
available AAC devices that are controlled by access methods such as touch, switch, head tracking and eye gaze;
however, these access methods become difficult or impossible to use when sustained muscle control is more
challenging or voluntary motor control is lost. There are brain-computer interface (BCI) communication
systems, such as the P300 speller, that use sensory stimulation to elicit and then detect sensory neural
responses in electroencephalography (EEG) data, and these communication aids do not require any motor
control on the part of the affected individual. However, the accuracies and spelling speeds of stimulus-driven
BCIs are suboptimal due to the inherent limitations associated with relying on sensory stimulation, which
generates highly variable neural responses, as well as the necessity of processing inherently noisy EEG data to
extract the relevant neural information that is needed to control the BCI. Current BCI communication rates can
potentially be improved with closed-loop optimisation techniques that exploit information from the user’s
responses to previous stimuli to optimally tune the BCI system’s parameters to achieve the desired goal of
maximising system performance under conditions of uncertainty. A closed-loop strategy can be used to select
stimuli that are maximally informative of the user’s intent given the neural responses that are being measured,
and I hypothesise that this data-adaptive approach to stimulus selection will minimise BCI decision errors and
achieve better device control. Conventional BCIs use open-loop stimulus control methods as the stimulus
presentation schedule is typically set in advance or occurs randomly, and there has been limited development
of closed-loop stimulus paradigms in BCIs. The goal of the research that I propose is to investigate the
feasibility of a novel closed-loop stimulus selection algorithm that will optimise the BCI stimulus presentation
schedule in real-time based on the measured EEG data and the BCI system’s belief about the user’s intent, with
proof-of-concept demonstrated in the P300 BCI speller. Specific Aim 1 will initially develop and test the novel
algorithm in a non-disabled cohort to leverage the time efficiency and practicality of non-disabled participant
studies to evaluate the real-time feasibility and potential utility of the closed-loop stimulus selection algorithm.
Specific Aim 2 will test the closed-loop stimulus selection algorithm in individuals with ALS to assess the
performance of the algorithm in a clinically relevant cohort. The successful development and testing of the
proposed closed-loop stimulus selection algorithm in a challenging system such as the P300 BCI speller has the
potential to instigate a paradigm shift towards closed-loop methods for BCI control and other applications
where optimising system parameters in real-time to improve overall system performance could be of benefit.

Public health relevance
Project Narrative People with significant motor disabilities often require assistive devices such as augmentative and alternative communication (AAC) systems to communicate and interact with their environment. Brain-computer interfaces (BCIs) can provide access to AAC systems and other devices for individuals with little to no voluntary muscle control in order to facilitate their communication with the outside world; however current BCI communication accuracies and speeds are suboptimal. The goal of this research effort is to develop and test the use of closed-loop optimisation techniques in BCI system design, where information from previous user responses and actions by the system is considered during the selection of the next action of the system. These closed loop techniques will be used to optimise BCI stimulus presentation parameters during real-time use to improve BCI communication efficiency, and demonstrated success of the proposed closed-loop stimulus optimisation method in real-time BCI use has the potential to accelerate the translation of BCI systems into viable AAC devices.